Fluoroscopic drill attachment for orthopedic trauma surgery

Abstract
For about 175,000 leg and hip fractures each year, the best treatment is for an orthopaedic surgeon to implant
a stiff metal rod, or intramedullary (IM) nail, through the center of the bone and fix the nail to the bone with screws
(distal locking). Distal locking can be difficult and time-consuming step and presents two major challenges. First,
the procedure uses C-arm fluoroscopy for guidance and exposes surgeons to radiation. For surgeons with high
case volumes (Level 1 and 2 trauma centers), this results in higher rates of radiation exposure. Recent studies
have demonstrated that the commonly held notion that exposure is negligible is misleading and most orthopaedic
surgeons are inadequately protected. Second, the procedure requires a high rate of precision to avoid less than
ideal patient outcomes, such as limb malrotation. Orthopaedic generalists experience alignment challenges more
often due to smaller case volumes. Difficulty during this procedure also affects patients with longer surgery times,
additional blood loss and increased radiation exposure. A faster and safer method is needed to reduce radiation
exposure and improve patient outcomes. Eclipse Orthopaedics (EO) is a startup focused on improving internal
fixation procedures. Based on patented technology, Eclipse Orthopaedics is developing a freehand targeting
device, the Radiographic Targeting Attachment™ (RTA) that puts both targeting and drilling capabilities literally
in the surgeons’ hands. The RTA combines a small X-ray source and a drill attachment that, when paired with
the imager and drill, becomes a fluoroscopically-guided drill that locates and drills holes in one operation. EO is
currently developing this technology while pursuing a licensing agreement with a major trauma supplier, who will
market the RTA as an integral part of their internal fixation product portfolio. Building off of extensive preliminary
data as well as customer knowledge gained through over 100 customer interviews during I-Corps and an NIH
Niche Assessment, the goal of this Direct to Phase II is to complete a multi-site study among a wide range of
orthopaedic surgeons. The Direct to Phase II project has been designed in response to the FDA’s medical device
design control guidance document. Specific Aims are as follows: (Aim 1) Design, build and verify prototype,
which will reduce the radiation dose to less than half the standard method. (Aim 2) Verify effectiveness and
usability in a multi-site cadaver study. (Aim 3) Begin design control, define regulatory pathway, and improve the
RTA system. At the conclusion of the Direct to Phase II, Eclipse Orthopaedics will have the key system
performance data, human factors insights from evaluations of target users, and a well-defined regulatory path.
Eclipse will plan a comprehensive product development schedule in Phase IIB. EO is located in Warsaw, Indiana,
an epicenter of orthopaedic innovation and industry. Leveraging its industry relationships, EO will continue to
explore the already high interest in licensing from leading orthopedic device manufacturers.

Public health relevance
Narrative A common and successful treatment for long bone fractures is the implantation of a stiff metal rod, or intramedullary (IM) nail, through the center of the bone which is then fixed to the bone with screws. To anchor the nail securely, the surgeon must accurately drill pilot holes through both the bone and locking holes in the nail, while the nail is hidden from view. This challenging task and often results in longer surgery time, additional blood loss and radiation exposure and a risk of malrotation of the extremity. In this SBIR, Eclipse Orthopaedics will develop a device to significantly improve the freehand targeting of IM nails based on Eclipse’s patented technology.